Glucagon-like peptide-1 receptor agonists in lupus

Project Summary/Abstract
Systemic lupus erythematosus (SLE) is a chronic autoimmune disease associated with excess morbidity and
premature mortality. Up to half of all patients with SLE will develop lupus nephritis, which also contributes to
heightened risks of cardiovascular (CV) events and end-stage kidney disease (ESKD). These adverse
outcomes are driven by a combination of uncontrolled lupus disease activity, chronic tissue damage including
proteinuric nephropathy, and glucocorticoid toxicity, which exacerbates conventional CV risk factors. A major
unmet need in lupus care is to improve kidney and CV outcomes, and novel treatment approaches are needed.
Glucagon-like peptide-1 receptor agonists (GLP-1RAs) are a class of anti-obesity and hypoglycemic agents
with pleiotropic cardioprotective, nephroprotective, and anti-inflammatory effects. These medications have
been found to prevent major adverse cardiac events (MACE) and reduce kidney disease progression in non-
SLE populations, including those with overweight/obesity and/or type 2 diabetes. Our central hypothesis is that
GLP-1RA medications will have similar to greater benefits in patients with SLE. The goal of this proposal is to
investigate the potential role for GLP-1RA to improve outcomes for patients with SLE and lupus nephritis. In
Aim 1, we will leverage a large SLE cohort in an administrative healthcare database to emulate target trials to
test the hypothesis that GLP-1RA use versus no GLP-1RA use will reduce the risk of MACE and kidney
disease progression, including new-onset ESKD, among patients with SLE and overweight/obesity. We will
also utilize an electronic health record (EHR)-based SLE cohort from multiple academic and community
hospitals to test the hypothesis that GLP-1RA use among patients with SLE will be associated with
improvements in conventional CV risk factors (including blood pressure, cholesterol, and body weight/body
mass index) and a reduction in proteinuria in the subgroup of patients with lupus nephritis. In Aim 2, we will use
the same EHR-based SLE cohort to test the hypothesis that GLP-1RA use will be associated with a lower risk
of lupus flares and reduced biomarkers of disease activity. The anticipated findings will provide critical
evidence for the potential benefits of GLP-1RAs in treatment of patients with lupus. If successful, the
anticipated findings will lead to a new treatment paradigm and improvements in SLE care.

Public health relevance
Project Narrative Systemic lupus erythematosus (SLE) is a heterogeneous systemic condition associated with serious morbidity including kidney failure and cardiovascular events, and new treatment approaches are needed to improve these outcomes. Glucagon-like peptide-1 receptor agonists (GLP-1RAs) are hypoglycemic medications that have been found to prevent cardiovascular events and reduce kidney disease progression in people with diabetes and/or obesity, due to multiple glucose-independent hemodynamic and anti- inflammatory effects, and they may impact autoimmunity. The goal of this proposal is to determine the potential role for GLP-1RAs to improve outcomes for patients with SLE and lupus nephritis, including the prevention of kidney failure cardiovascular events and the reduction of lupus disease activity.